Optimization of aminolevulinic acid-protoporphyrin IX for fluorescence-guided tumor resection and treatment

NCI Diversity Supplement Application
Parent grant: Optimization of aminolevulinic acid-protoporphyrin IX for fluorescence-guided tumor
resection and treatment (R15CA268200-02, PI: Bin Chen)
This diversity supplement application is to support Ms. Jordyn Olsen, a first-generation college graduate in her
family, to pursue PhD training in cancer research with the goal of promoting women and minorities in cancer
research workforce. Aminolevulinic acid (ALA) is one of a few FDA-approved intraoperative fluorescent probes
and the only molecular probe based on the metabolic alterations in tumor cells. ALA has no fluorescence on its
own and needs to be metabolized in the heme biosynthesis pathway in tumor cells to produce a fluorescent and
photosensitizing metabolite protoporphyrin IX (PpIX), which enables tumor fluorescence imaging for tumor
detection and photodynamic therapy (PDT) for cancer treatment. Although ALA-PpIX has been clinically used
for fluorescence-guided tumor resection and cancer treatment, its applications are limited by low tumor PpIX
fluorescence, high tumor fluorescence heterogeneity, and low tumor-to-normal tissue fluorescence contrast.
Research supported by the parent grant has led to the identification of ABCG2 transporter activity as a critical
factor in reducing tumor PpIX fluorescence. More importantly, we have identified clinically used agents to
suppress ABCG2 activity to enhance tumor PpIX fluorescence. In this supplement research, Jordyn will
determine whether variation in ABCG2 expression results in intra-tumor and inter-tumor heterogeneity in ALA-
PpIX fluorescence. In addition, she will investigate whether PpIX fluorescence heterogeneity in tumor cells can
be suppressed by ABCG2 inhibition. This proposed research is related to the on-going work supported by the
parent grant funding and will further expand scope of parent grant research. Support from this supplement
funding will enable Jordyn to complete the necessary training in cancer research so that she will have the
knowledge and skills to start her career as a cancer researcher.

Public health relevance
This supplement research focuses on addressing the intra- and inter-tumor heterogeneity of 5- aminolevulinic acid (ALA)-mediated protoporphyrin IX (PpIX) fluorescence so that ALA can be better used for tumor detection and photodynamic therapy. This application is also important for supporting a first-generation female college graduate to start her future career as a cancer researcher.